An Optimization trial of a stakeholder-enhanced intervention to improve the decisional partnership of Chronic Kidney Disease dyads using the multiphase optimization strategy: Project ImPart.

PROJECT SUMMARY
This K23 application resubmission describes the background and experience of the applicant, Shena
Gazaway, PhD, RN, and her plan to acquire the necessary skills to become a leading independent scientist
focused on developing and testing stakeholder, early health-related decision support interventions to improve
upstream decision-making among patients with chronic kidney disease (CKD) and their family caregivers. The
proposed research is critical because: 1) persons living with CKD and their family members have numerous
unmet needs related to health-related decision-making, and 2) sparse prior work has examined the
mechanisms underlying health-related decision-making or investigated which stakeholder-informed
intervention components can result in positive effects while also being scalable. The specific training objectives
for the K23 are to gain advanced expertise and skills in: 1) leading the design, conduct, and statistical analysis
of optimization clinical trials within the Multiphase Optimization Strategy (MOST) framework; 2) developing
stakeholder-informed, early decision support interventions with advanced CKD populations; and 3) training in
advanced ethics in human subjects research. Meeting these training objectives will enable Dr. Gazaway to
achieve the overall goal of the K23 to conduct a pilot randomized 23 factorial trial to test components of an
early health-related decision support training intervention –ImPart (Improving Decisional Partnership for CKD
dyads) for adults living with stage 4 CKD and their caregivers. The goal of ImPart will be to train the CKD dyad
with the decision partnership and communication skills necessary to navigate advanced CKD as activated
partners before facing major health-related decisions (e.g., kidney transplant, dialysis, end-of-life decisions). A
comprehensive training plan has been developed under the guidance of the mentorship team of senior
research experts. The plan includes intensive one-on-one mentorship, formal coursework/workshops, clinical
trial observerships, and conference attendance. In partnership with a 6-member stakeholder group (CKD
patients, caregivers, and clinicians), we will finalize ImPart components and component levels for piloting. The
specific aims of this K23 are - 1) to determine acceptability & feasibility of the refined intervention components
in a sample of 64 dyads over 24 weeks using a pilot factorial design and 2) to explore the preliminary efficacy
of individual intervention components on patient and caregiver outcomes over 24 weeks on decisional conflict
(primary outcome). The results from these proposed activities will directly support an R01 application to
conduct a fully powered MOST factorial trial to test the effects of individual ImPart components on CKD patient
and caregiver outcomes.

Public health relevance
PROJECT NARRATIVE Many of the estimated 37 million U.S. adults living with Chronic Kidney Disease (CKD) rely on unpaid family and friend caregivers to assist with disease management and navigate health-related decision-making. However, a significant gap in the literature highlights the necessity to develop and test interventions designed to train patients with CKD and their caregivers to be activated members of the shared decision-making team. This project aims to equip CKD patients and their caregivers with the skills needed to be activated members in shared decision-making before illness advances.